ETIOLOGY OF ALLERGIC REACTIONS IN PLATELETPHERESIS DONORS

In February, 1984, the DTM converted from manual to automated platelet collection techniques, acquiring for this purpose four automated cell separation devices. During the next 3 years, 11 donors undergoing apheresis procedures on the Fenwal CS-3000 device experienced acute hypersensitivity reactions. Nine reactions occurred during plateletpheresis and 4 reactions occurred during granulocytapheresis procedures. The purpose of this study was to identify the allergen responsible for these reactions. Using a combination of skin tests, radioallergosorbent tests, and basophil histamine release assays, specific IgE- mediated sensitization to ethylene oxide, a gas used to sterilize the plastic disposable apheresis kits, was found in all plateletpheresis donors experiencing reactions, but in none of 100 non-reacting controls. Preliminary data also suggests that ethylene oxide is the agent responsible for hypersensitivity reactions during granulocytapheresis. It is estimated that as many as 1.0% of all repeat apheresis donors may become sensitized to ethylene oxide and experience allergic symptoms during donation. Although none of these reactions have been life- threatening, the DTM is continuing to test apheresis donors from sensitization to ethylene oxide, and to defer sensitized individuals from subsequent CS-3000 donations.